University of Texas PDX Development and Trial Center

PROJECT SUMMARY/ABSTRACT
This application is being submitted in response to the Notice of Special Interest (NOSI) identified as NOT-CA-
22-039. Triple negative breast cancer (TNBC) accounts for 10-20% of all breast cancers, and is one of the most
aggressive. Patients with metastatic TNBC are at high risk of death1,2 despite standard-of-care chemotherapies
such as eribulin, a halichondrin analogue that inhibits microtubule dynamics. Previously, we found that selinexor
(KPT-330), a potent inhibitor of exportin-1, synergizes with eribulin in TNBC cells and patient-derived xenografts
(PDXs). Based on these studies, we launched a Phase Ib trial combining selinexor and eribulin, with expansion
in TNBC (NCT02419495). Overall response rate was 10.5% in TNBC dose expansion (n = 19); however, two
patients had exceptional responses with confirmed durable partial response, maintained long-term after
transitioning to single-agent selinexor. We now propose to investigate the mechanism of action of this
combination. We hypothesize that integrated analysis of PDXs and patient samples will give insights into the
individual contributions of eribulin and selinexor to treatment efficacy, and into potential predictors and
pharmacodynamic markers of response that can facilitate the design of follow-up trials using eribulin as
chemotherapy backbone, in particular a randomized Phase II trial of eribulin with and without selinexor, to be
launched through the Experimental Therapeutics Clinical Trial Network (ETCTN). To this end, we will (a)
investigate whether selinexor enhances the efficacy of eribulin in TNBC PDXs established during the
eribulin/selinexor trial, and whether efficacy of the combination in PDXs correlate with clinical efficacy; (b)
compare baseline molecular features in PDXs and patient samples from responders and nonresponders; (c)
compare pharmacodynamic changes in PDXs from responders and nonresponders following single-agent
eribulin or selinexor and combination; and (d) compare pharmacodynamic changes in PDXs and in matching
pre-treatment and on-treatment patient samples. The proposed study represents a PDXNet/ETCTN
collaboration between Drs. Funda Meric-Bernstam and Senthilkumar Damodaran, and is consistent with our
long-term goal to leverage PDXs and molecular profiling to identify rational combination therapies that will
improve TNBC outcomes, as well as to identify patients who can benefit from such therapies. Taken together,
we expect to better understand (a) whether selinexor improves efficacy of eribulin, (b) whether PDX efficacy and
pharmacodynamic changes correlate with what is seen in patients, and (c) what tumor features correlate with
response.

Public health relevance
PROJECT NARRATIVE There is an urgent need to develop more effective and more durable treatments for patients with triple-negative breast cancer, who are at high risk of relapse and death. We now propose to perform a co-clinical trial with PDXs to investigate why, in a previous clinical trial, some patients responded exceedingly well to a combination of the drugs selinexor and eribulin, while many others did not. We anticipate that these studies can help improve clinical outcomes from triple-negative breast cancer by (1) identifying those patients for whom this combination will likely be effective, and (2) by identifying alternative drugs that can potentially be combined with eribulin for those other patients for whom this combination is not a viable option.